Epigenetic Regulation of KSHV

PROJECT SUMMARY/ABSTRACT
Kaposi’s Sarcoma-associated herpesvirus (KSHV), also known as Human Herpesvirus 8 (HHV8), is the
etiological agent of the human malignancies Kaposi’s sarcoma (KS), primary effusion lymphoma (PEL), and
multicentric Castleman’s disease (MCD). KS is the most common AIDS-defining malignancy and represents the
leading cause of cancer in sub-Saharan African men. Despite KSHV associated malignancies having a unifying
variable (KSHV), no effective viral specific biomarker exists. Current viral monitoring commonly relies on crude
viral PCR load levels, is not informative of viral activity, and is not currently recommended for monitoring of
disease response within National Comprehensive Cancer Network (NCCN) guidelines.
KSHV establishes lifelong infection and generally exists in either a latent or lytic state. Latency is the
default state and is characterized by viral expression of a very limited subset of genes. On the other hand, lytic
is full expression of the viral genome with production of infectious progeny. KSHV derived malignancy is thought
to depend on gene products from both latent and lytic states. Therefore, understanding regulation of KSHV
latent/lytic balance has long been a highly sought after goal. Epigenetic regulation of viral genes is a well-known
mechanism for gene control; however, this remains an incompletely explored area within KSHV, particularly in
regards to viral DNA methylation. Previous work has shown variation in KSHV DNA methylation patterns globally
in cell lines and at the lytic origin of replication in primary samples. We hypothesize that KSHV DNA methylation
is dynamic during latent/lytic shift and that overall patterns will be predictive of viral activity in vivo which may
represent a novel biomarker. To explore KSHV DNA methylation, we have created a novel approach for high
throughput multi-locus methylation investigation within KSHV samples. We propose to characterize KSHV
methylation dynamics in vitro during latent/lytic states utilizing this approach. Further, we aim to validate overall
KSHV methylation pattern as a novel biomarker for KSHV associated disease by analyzing primary patient
samples from an internal biorepository and from a clinical trial .
Collectively, the proposed studies will fill a distinct gap in our basic understanding of KSHV virology; DNA
methylation dynamics during the crucial latent/lytic shift and in differing disease contexts. Additionally, we aim to
generate a novel biomarker in KSHV associated disease to be utilized as a potential proxy of viral activity,
disease response, and prognosis.

Public health relevance
PROJECT NARRATIVE Kaposi’s sarcoma-associated herpesvirus (KSHV) causes 3 human cancers including Kaposi’s sarcoma, primary effusion lymphoma, and multicentric Castleman’s disease. Tight viral gene epigenetic regulation is vital for disease development and represents an underexplored area in KSHV basic virology. We propose to investigate KSHV DNA methylation dynamics to inform our understanding of KSHV virology and with an aim to develop a novel biomarker for KSHV associated diseases.